Discovery of PD-1/PDL-1 inhibitors from marine microbial natural products

Project Summary and Relevance
Project Summary:
The broad, long-term objective of this collaborative project is the discovery of small molecule
therapeutics that can replace antibodies as inhibitors of the PD-1 checkpoint. To date, no small
molecules have been approved for this application, although the benefits of small molecules
over biologicals in drug therapy is clear. This project capitalizes on the existence of a large
collection (up to 30,000 samples) of structurally unique marine microbial metabolites that have
shown to be a solid source for the development of anticancer agents. This collection, available
at the Scripps Institution of Oceanography, UCSD, from Dr. William Fenical will be interfaced
with the cancer biology lab of Dr. Yin Lu at the Nanjing University of Chinese Medicine, to
screen for selective inhibitors using a commercially-available cell-based bioassay for PD-1
binding. When active metabolites are discovered, they will be screened in a variety of secondary
assays to show selective binding. Finally, verified PD-1binding inhibitors will be produced in
multi-milligram amounts by large-scale cultivation and provided to Dr. Lu for evaluation in
mouse and rat xenograph models of select cancers.
Relevance:
This project aims to improve on the immunotherapy of cancer by discovering small molecules
that selectively bind to the protein PD-1, which when bound to PDL-1 is responsible for the
deactivation of the immune system. Replacing the current antibody (protein) therapy with a
small molecule drug is likely to improve treatment efficacy and will clearly reduce drug cost.

Public health relevance
Project Narrative In this project, Drs. Lu and Fenical aim to collaborate in the discovery of new drugs that enhance the immune system to more effectively combat cancer. The researchers will focus their discovery effort on new drug candidates found in the ocean’s microorganisms, a resource never examined for natural drugs. Their approach involves testing marine natural products for their ability to bind to a specific protein, called PD-1 that is involved in the human immune system in combating the onset of cancer.